New innovations: advancing mast cell biology

Summary: Mast cells are the main drivers of diseases including mastocytosis, mast cell activation syndrome
(MCAS), allergic inflammation and deadly anaphylaxis reactions. Once activated, mast cells promote
inflammation through their robust production of histamines, leukotrienes, prostaglandins and many other
effector molecules that promote itching, burning, smooth muscle contraction and anaphylaxis; all of which are
common symptoms of mast cell-mediated inflammation. Although patients suffering from these symptoms are
prescribed antihistamines and mast cell stabilizers, treatment options are limited, and severe forms of these
diseases remain life-threatening. Further, an incomplete understanding of the factors that regulate mast
cell development has dramatically limited the ability to design novel therapeutics that selectively target
mast cells. Our recent studies have revealed that the enzyme carbonic anhydrase (Car)1 is exclusively
expressed by mast cell progenitors. Further, we have demonstrated that pharmacologic inhibition of Car1 is
sufficient to prevent murine and human mast cell development. Moreover, our data demonstrate that in vivo
treatment with carbonic anhydrase inhibitors is sufficient to prevent mast cell development and inflammation in
murine models of infection, allergic inflammation and mastocytosis. Collectively, these studies identify Car1 as
a critical regulator of mast cell development and a novel therapeutic target for the treatment of mast cell-
mediated inflammation. Despite these significant advances, whether mast cells exclusively arise from Car1-
expressing progenitors at baseline and in the context of inflammation remains to be defined. Further, the
therapeutic potential of specifically targeting Car1-expressing progenitors is unknown. To address this, we
have generated a novel mouse model with a tamoxifen (TAM) inducible Cre recombinase under control of the
Car1 promoter. We will use this newly developed mouse model to answer these important questions: Aim 1
will perform fate mapping experiments to systematically evaluate the contributions of Car1-expressing
progenitors to the population expansion of mast cells in response to diverse stimuli. Aim 2 will perform lineage-
specific deletion experiments to target Car1-expressing progenitors and test their contributions to diverse forms
of mast cell-mediated inflammation. These important studies will help to validate a novel mouse model that, for
the first time, can specifically delete mast cell progenitors. Given the substantial knowledge gaps in our
understanding of mast cell development, this new tool has the potential to promote significant advances in
mast cell biology.

Public health relevance
PROJECT NARRATIVE Mast cells are the main drivers of diseases including mastocytosis, mast cell activation syndrome (MCAS), allergic inflammation and deadly anaphylaxis reactions. Despite their clinical importance the progenitor cells and factors that regulate mast cell responses remain to be fully defined. This proposal will support the development of a new mouse model that will allow us to definitively identify mast cell precursors and evaluate the therapeutic potential of targeting these cells.